AMD Ryan Initiative Study (ARIS)

The ARIS is just being launched. We are currently recruiting the 20 US and international centers for the enrollment of the participants. The contracts and the protocols along with the manuals of operations are currently written. Approvals from the various IRBs are still pending for the European investigators. The reading center is complete with the certification of the equipment and the personnel for measurement of the functional studies that are activated. There are few more European sites to be certified. We have recruited 12 participants with 2 more pending eligibility at the NEI clinical center. This is a multicenter study which is led by the NIH leadership. This natural history study will hopefully have recruited fully within the next 12 to 18 months.